Administrative Core

ABSTRACT – ADMINISTRATIVE CORE (CORE A)
The Developmental and Hyperactive Ras Tumor (DHART) SPORE was funded in 2015 with the goal of
implementing effective targeted molecular therapies for neoplasms and cancers characterized by NF1
mutations by conducting integrated, mechanistically based translational research. The studies proposed in our
renewal will continue to address the fundamental problem of hyperactive Ras signaling in cancer. The
program consists of three research projects and three core components. Innovative aspects of the DHART
SPORE include: (1) a focus on advancing the science and care of patients with orphan diseases; (2) a strong
emphasis on tumors arising in young children, adolescents, and young adults; (3) studies of diverse tumor
types that share a common driver mutation; and, (4) an investigative team drawn from leading research
centers across the nation to promote integration of preclinical and clinical trials expertise and patient access.
The goal of the Administrative Core is to provide scientific and administrative oversight for all the program
components of the DHART SPORE. This core serves as the central point for all administrative activities and
essential services, including being the organizing unit for the coordination, integration and communication for
all components. These coordinating components include: 1) providing the overall organizational framework by
which researchers communicate and interact/collaborate, 2) managing finances, 3) supporting the coordination
of the review of progress of the research projects, scientific cores and developmental programs (DRP and
CEP), 4) consulting with the members of the External and Internal Advisory boards, 5) coordinating the overall
data integration and analysis of the DHART SPORE, and 6) continuing to establish and refine the infrastructure
to support the meaningful sharing of data and information generated through our studies with other internal and
external NF-collaborative consortiums.

Public health relevance
PROJECT NARRATIVE – ADMINISTRATIVE CORE (CORE A) The DHART SPORE currently encompasses three highly integrated projects and three cores with the goal of implementing effective targeted molecular therapies for neoplasms and cancers characterized by NF1 mutations by conducting integrated, mechanistically based translational research. The goal of the Administrative Core is to provide scientific and administrative oversight for all the program components of the DHART SPORE. The core will provide the overall organizational framework by which researchers communicate and interact, manage finances, coordinate the review of progress of the research projects, scientific cores and developmental programs (DRP & CEP), consult with the members of the External and Internal Advisory boards, coordinate the overall data integration and analysis of the DHART SPORE, and continue to refine our infrastructure to enable sharing of data generated by our studies with other internal and external NF-collaborative consortiums.